Developing a Patient Navigation Intervention to Improve Risk Management among Women at High Risk of Breast Cancer

Project Summary/Abstract
Women with a family history and/or genetic predisposition for breast cancer (BC) can face significantly
elevated lifetime BC risk, but the cancer risk management options (i.e., surveillance routines, preventive
surgeries, and medications) that are shown to reduce risk and enable early detection are used by only a small
proportion of women for whom they are recommended. There is a critical need to develop evidence-based
strategies to improve the standard of care for high-risk women. Population-based screening programs, usually
facilitated through screening mammography services, offer significant promise of identifying most high-risk
women. Effectively reducing BC morbidity and mortality, however, also requires additional steps to
communicate personalized risk information and risk-management options; connect women with healthcare
providers capable of explaining risk, its consequences, and risk-management options; support risk-related
decision making; and facilitate risk-management decisions and behavior. Prior research has illuminated (a) a
staged pathway along which high-risk women adopt risk-management behavior and (b) eight main facilitators
(related to information, support, beliefs, access to care, and resolution of practical barriers) that help advance
women along the risk-management adoption pathway (R-MAP). In addition, survey-based studies have
demonstrated that the majority of high-risk women experience significant gaps in access to these facilitators,
and that these gaps are particularly acute among Black women. The goal of the proposed study is to design,
develop, and test a multi-dimensional patient navigation (PN) intervention to advance high-risk women along
the risk-management adoption pathway by addressing the eight main facilitators of risk-management behavior.
Aim 1: Determine the specific information, types of support, barrier reductions, and provider referrals that
would advance women at high risk of BC along the pathway toward risk-management adoption, using semi-
structured interviews with high-risk Black and White women. Aim 2: Develop a multi-dimensional PN
intervention to advance high-risk women along the risk-management adoption pathway, guided by data
generated in Aim 1 and a panel composed of experts and patient representatives. Aim 3: Test the feasibility of
the PN intervention and of recruiting to a participants to a randomized controlled trial of the intervention.
Seventy-five participants identified after a screening mammogram as potentially at high BC risk will be
randomized to PN-intervention or information-only conditions in a 2:1 ratio. Baseline surveys and final surveys
after eight months will be used to assess the primary hypothesis that most intervention-arm participants will be
satisfied with the PN intervention, and to check several other benchmarks of feasibility. We will also
descriptively estimate progress along the R-MAP and other outcomes, to appropriately power a randomized
controlled trial (RCT) to come. This research will set the stage for a full-scale RCT of this innovative
intervention with racially and socioeconomically diverse populations, and ultimately contribute to cancer
prevention and control among high-risk women.

Public health relevance
Project Narrative This project aims to improve public health by developing a novel approach to guide diverse women at high risk of breast cancer toward the adoption of risk-management behaviors, which may include enhanced surveillance routines, preventive surgeries, and medications. We will develop and test the feasibility of an intervention that involves patient navigators interacting with individual patients over an extended period to offer information about breast cancer risk and risk-management options, shape beliefs about breast cancer risk, provide emotional support for risk-related coping, connect women with specialists who can provide personalized information and risk-specific care, and address financial and other practical barriers to medical care. The project is responsive to NCI’s mission and PAR-19-309 because it will lay the groundwork for an innovative behavioral approach to cancer prevention and control among diverse high-risk populations.